Omuyambi: Traditional healer support to improve HIV viral suppression in rural Uganda

PROJECT SUMMARY AND ABSTRACT
People living with HIV (PLWH) in rural sub-Saharan Africa are three times less likely to achieve viral
suppression than their urban counterparts. Novel HIV service delivery models for rural PLWH are needed to
improve the HIV continuum of care and achieve viral suppression. Traditional healers (TH) are lay providers
who serve as the first line of healthcare in rural Africa, and frequently provide care to PLWH who have
disengaged from HIV care. TH are accessible, trusted members of rural communities, but have not been
integrated into HIV care programs. Our prior cluster randomized trial demonstrated that partnerships with TH
quadrupled the uptake of HIV testing in rural Uganda through facilitation of HIV counseling and self-testing.
Building on these results, we adapted an evidence-based lay provider intervention for delivery by Ugandan TH
to support subsequent steps of the HIV continuum. The TH-delivered program is called Omuyambi (“Support”
in Runyankole) and includes assisting PLWH to link to care for ART initiation, providing ongoing counseling on
ART adherence, and encouraging retention in clinical care. We conducted a pilot study of this lay provider
program among 12 TH and 20 PLWH who were disengaged from HIV care or ART naïve. Results were
overwhelmingly positive: 100% of PLWH linked to HIV care and initiated ART within 14 days, 95% reported
ART adherence and 100% were retained in care after nine months. Building upon this evidence, we
hypothesize that TH can support clinic-based care and improve viral suppression among rural PLWH. We
will conduct a hybrid type I effectiveness-implementation cluster randomized trial to evaluate the effectiveness
of the Omuyambi intervention on viral suppression among ART naïve/defaulted PLWH in Uganda.
• Aim 1: Compare the Omuyambi intervention versus routine HIV clinic-based care (control) in a cluster
randomized trial. Forty TH clusters that include ≥650 PLWH will be randomized to the Omuyambi intervention
or to a control arm, in which TH will refer PLWH to clinic-based HIV care alone. Primary clinical outcome is
viral suppression at 12 months measured via dried blood spot analysis. We hypothesize that 80% of PLWH in
the intervention arm will achieve viral suppression, compared with 60% in the control arm.
• Aim 2: Evaluate implementation of Omuyambi using a convergent mixed methods study design and the
Consolidated Framework for Implementation Research (CFIR). Qualitative and quantitative data will be
collected from participating TH, PLWH, HIV clinic staff, and Ministry of Health Officials. These data will be used
to assess Omuyambi implementation determinants and outcomes.
The proposed research is significant as it responds to the World Health Organization and Ugandan Ministry of
Health calls for community-based interventions to improve HIV viral suppression where current programs
have suboptimal impact. If effective, this approach has the potential to improve the HIV continuum among rural
PLWH towards UNAIDS 95-95-95 benchmarks necessary to end the HIV epidemic.

Public health relevance
PROJECT NARRATIVE HIV infection disproportionately affects rural communities in sub-Saharan Africa, leading to high rates of mortality and fueling ongoing transmission. The proposed research seeks to engage and support rural people living with HIV in Uganda through local traditional healers as an adjunct to routine clinical care, with the goal of improving viral suppression and thereby reducing HIV-associated morbidity and transmission. This proposal aligns with the National Institutes of Health’s mission to foster “innovative research strategies … for ultimately protecting and improving health”, and is responsive to the National Institute of Mental Health’s goal of supporting research to improve the HIV continuum of care in order to reduce HIV deaths and infections worldwide.